Immune mechanisms of pain of the IL-23IL-17 Axis in Inflammatory Arthritis

Project Summary/Abstract
The IL-23/IL-17 axis is implicated in many autoimmune and autoinflammatory disorders including
psoriatic arthritis, a chronic and progressive inflammatory arthritis closely linked with psoriasis.
We have been studying the IL-23/IL-17 axis in inflammatory arthritis through the NIH award
R01AR062173 and investigated the tissue destructive process of inflammation as it relates to
bone and skin degeneration. Herein we propose to study the immune mechanisms of the IL-23/IL-
17 axis in pain as part of the Notice of Special Interest (NOSI): NOT-AR-23-015 Urgent
Competitive Revisions to Add Research on Cutting Edge Pain Research in Rheumatic, Skin, and
Musculoskeletal Disease. Specifically, this supplement will address the cellular and molecular
mechanisms that are responsible for pain. We will therefore adapt the animal models and in
conjunction with pain readouts facilitated by our collaborators we will identify the effectors and
transducers that mediate immune pain in inflammatory arthritis. Our two specific aims will address
the effect of myelopoiesis via GM-CSF+ innate lymphoid cells and the development of IL-17A+
myeloid cells that were recently associated with pain. Our work will uncover the pathogenic
mechanisms of immune pain and uncover novel molecular targets that can be exploited for
therapeutic intervention and directly benefit arthritis patients worldwide.

Public health relevance
Project Narrative The interleukin IL-23/17 axis has pleiotropic effects in immunity. Its uncontrolled expression leads to autoimmunity and pathologic features consistent with inflammatory arthritis. This supplement will be focused on elucidating the cellular and molecular immune mechanisms of pain that controlled by the IL-23/17 axis and identify selective targets that can be exploited therapeutically in order to improve the quality of life of arthritis patients.